Novel Copolymer-based Cell Membrane Stabilizers to Attenuate Myocardial Infarction

Project Summary / Abstract
As a board-certified VA anesthesiologist and cardiovascular physiologist I study protective mechanisms
against ischemia/reperfusion (IR) injury ultimately geared to help our often multi-morbid patients. Veterans
frequently suffer from atherosclerosis, including coronary artery disease, and, therefore, have a high incidence
of myocardial infarction, with often debilitating functional consequences if surviving. Paradoxically, abrupt
reperfusion, i.e., reintroduction of blood flow after prolonged ischemia, and its concomitant molecular and
metabolic changes may be more detrimental than the injury caused by the initial ischemia itself. Accordingly,
our revised application focuses on mitigating myocardial IR injury by administration of known and newly
designed synthetic copolymer-based cell membrane stabilizers (CCMS) given on reperfusion, and on
elucidating their protective mechanisms of action. For this original area in cardiovascular research, we
propose to use: 1) individual cell cultures and co-cultures of coronary artery endothelial cells and
cardiomyocytes; and 2) an isolated, intact heart preparation of myocardial infarction. These will complement
each other in focusing on novel mechanisms of myocardial protections by CCMS. Our inter-disciplinary
research team from anesthesiology, physiology, and chemical engineering brings together expertise with a
wide spectrum of scientific qualifications that combine fields of basic science and medicine that normally have
minimal to no interaction in translational research. As such, we are uniquely positioned to enhance our
understanding of the complex pathophysiological processes that take place during and after prolonged
myocardial IR and to find innovative ways to increase survival, functional recovery and quality of life in
thousands of critically ill patients each year. Thus, findings from this highly innovative project may result in
novel treatments for victims of heart attacks and may have important implications on the optimal medical care
for patients, especially in our vulnerable Veteran population.

Public health relevance
Project Narrative As a VA anesthesiologist and physiologist I study novel strategies against cellular injury from heart attacks. Because many Veterans suffer from atherosclerosis, including coronary artery disease, Veterans have a high incidence of myocardial infarction, with often disabling outcomes. This further revised research proposal aims to investigate a known and a newly designed and improved synthetic membrane stabilizer, and their protective mechanisms to largely ameliorate the deleterious consequences of myocardial ischemia/reperfusion injury. Our inter-disciplinary research team with investigators from anesthesiology, physiology, and chemical engineering brings together expertise that combines fields of basic science and medicine that normally have minimal interaction in research. Results from our highly translational research may result in novel treatment options for heart attack victims. Thus, this project has important potential implications for the optimal medical care for our Veteran patients.